Use of Time Series Biomarker and Clinical Data to Construct a Time Trajectory Host Response Map

Principal Investigator/Program Director (Last, first, middle): Reddy, Jr., Bobby
Project Summary:
Sepsis is an incompletely understood clinical syndrome characterized by a dysregulated host response to
infection. In partnership with 8 U.S. hospitals, Prenosis amassed one of the world’s largest datasets and biobanks
that combines biomarker and clinical data for patients suspected of infection, housing over 70,000 plasma or
serum samples from over 14,000 patients. We also curated a dataset of dense time-series data from each
patient’s Electronic Medical Record (EMR), including demographics, vitals, lab results, interventions, outcomes,
and many other parameters. To commercialize insights from these data, Prenosis built ImmunixTM, an FHR/HL7
compatible software platform for clinical deployment of diagnostics and clinical decision support tools.
Under a previously awarded NIGMS grant (1R44GM139529), Prenosis built a testing pipeline to measure 40
critical protein biomarkers from biobanked samples. To date, we measured these biomarkers on only the initial
sample per patient for 6,000 patients and combined these data with EMR clinical parameters to construct 8
endotypes of sepsis. The identification and classification of endotypes—groupings of patients with similar
biologic and clinical features—is increasingly becoming recognized as a valuable methodologic approach to
assessing patients with sepsis. To complete work for the existing grant, Prenosis will measure the baseline
sample for additional patients to total about 10,000 patients to refine and validate the endotypes.
In this project, Prenosis proposes to add a critical new dimension to the data by assaying and analyzing
longitudinal, time-series biomarker data. We will leverage our pipeline to measure the 40 core biomarkers from
9,000 follow-up samples from ~3,400 patients that we have already collected and stored in the biobank. We
will assess the additional value of longitudinal time-series biomarker measurements and clinical data. Initial
feasibility data from over 1,000 measured samples demonstrates that longitudinal data provide additional
powerful new biologic and prognostic insights. Analytics built upon these data have the potential to improve
diagnostic and drug development products for sepsis and COVID. The overall hypothesis of this project is that
longitudinal biomarkers will add a valuable biologic and prognostic dimension to endotypes for sepsis; and these
longitudinal endotypes will better classify patients who may have a heterogeneous response to sepsis therapies.

Public health relevance
Principal Investigator/Program Director (Last, first, middle): Reddy, Jr., Bobby Project Narrative: In this proposed project, Prenosis intends to introduce a powerful new dimension to the existing NOSIS dataset by generating and analyzing longitudinal, time-series biomarker data that will be linked to the existing time series clinical data from hospital Electronic Medical Records. Using samples that have already been collected and stored in the biobank, we will leverage our existing measurement pipeline to measure the concentrations of 40 critical protein biomarkers from 9,000 follow-up longitudinal samples for ~3,400 patients. Analytics built upon such a dataset could dramatically improve diagnostic, clinical decision support, and drug development products for sepsis and COVID.